ANIMAL PHYSIOLOGY CORE

The Animal Physiology Core provides services to characterize the physiological parameters of rodent models of diabetes, obesity and their associated complications. These services include measurements in the categories of energy homeostasis, energy expenditure during exercise, vascular studies, ischemic tissue studies and glucose homeostasis. Energy Homeostasis: Feeding/drinking behavior, body composition, oxygen consumption and activity monitoring (CLAMS and DEXA). Energy Expenditure During Exercise: Oxygen consumption during rodent treadmill running (TM). Vascular Studies: Blood pressure measurements by tail blood pressure cuffs and by telemetry (BP). Ischemic Tissue Studies: The OxyCycler (OC) is an in vivo system that controls the ambient oxygen concentration allowing investigation of the effects of hypoxia or hyperoxia on various organs and tissues. Glucose Homeostasis: Monitoring of blood glucose and insulin levels, intraperitoneal glucose tolerance tests (GTT), insulin tolerance tests (ITT). Available upon request by an investigator for teaching purposes only.